Administrative Core - Drivers of influenza A virus transmission in humans

SUMMARY – Administra1ve Core
The proposed P01 Program centered at Emory University and coordinating with Virginia Tech will pursue the
primary goal of advancing fundamental understanding of influenza A virus transmission. The complexity of
transmission demands a research strategy that is well integrated and multi-disciplinary. The Administrative Core
to this program will therefore provide the constructive, collaborative environment needed to achieve the
program’s scientific objectives through the coordinated effort of a team of scientists with diverse and
complementary expertise. The Administrative Core will ensure smooth running of the project, with oversight over
financial considerations and reporting to NIH. Importantly, this Core will convene recurring meetings among the
Project and Core leads and ensure that lines of communication are consistently open. The Administrative Core
will also be responsible for ensuring the rich sample set acquired through the clinical studies is accessed in a
way that maximizes the data obtained from each sample and that data are effectively shared among program
components to ensure the most impactful avenues of data analysis are pursued. The Administrative Core will
achieve these goals by executing the overall management and coordination of P01 activities, facilitating
integration across Projects and Cores and acting as a centralized resource for communication of results to
external stakeholders. Through a highly innovative experimental approach and a synergistic combination of key
disciplines, the proposed program will bring major advances in fundamental understanding of influenza A virus
transmission.